Administrative Core

The purpose of the Administrative Core is to provide the administrative support needed for the design and implementation of this program project. The Administrative Core will facilitate the interactions between the different program projects to ensure optimal communication, planning, data sharing and fiscal accounting. The Specific Aims of the Core will be to provide fiscall oversight and overall management and coordination of the Program, ensure proper internal and external communications, establish and facilitate scientific review and planning, provide opportunities for training and career development, and develop, provide statistical consulting and oversee data and resource sharing. The Core will provide the staff support needed to administer the overall expenses for each of the separate projects and cores, and to insure fiscal responsibility. The Administrative Core will also assist in IRB application submissions and clinical trials reporting, report preparation, publication submissions, research and resource sharing, coordination of Internal Scientific Advisory Committee meetings, preparation of reports for the External Scientific Experts Group, and Internal Investigator meetings, and arranging scientific seminars and other communications between the investigators and the local research community.

Public health relevance
RELEVANCE (See instructions): The Kaposi's sarcoma (KS)-associated herpesvirus (KSHV) is the cause of KS and two other AIDS-related malignancies. KS is the most common oral tumor associated with HIV/AIDS and is one of the most common pediatric and adult tumors in Sub-Saharan Africa. This project will investigate the immune control, activation, transmission and pathogenesis of KSHV in order to develop effective vaccines and therapeutics for this devastating viral pathogen.